Multilevel Racism & Discrimination and PrEP Outcomes Among Black SMM in the Southeastern U.S.

PROJECT SUMMARY
Inequities in health manifest as a result of systemic minority stressors and social injustices. Racism and
discrimination are salient minority stressors and social injustices for Black sexual minority men (SMM) because
Black SMM anticipate and experience discrimination at different ecological levels (intrapersonal, interpersonal,
and community) due to their interconnected identities (e.g., race, sexual minority status, HIV status). These
multiple exposures concomitantly contribute to increased HIV vulnerability among Black MSM: 1 in 2 Black
SMM will be diagnosed with HIV in their lifetime, compared to 1 in 11 for White MSM, if current trends remain
unchanged. There is increasing interest in understanding an individual's ability to adapt to or resist life's
adversities or stressful events (i.e., minority strengths framework). Thus, an integrated minority social-structural
stress and minority strengths theory model will be tested in the proposed application to delineate the multilevel
discrimination predictors of HIV prevention outcomes, and understand how resilience moderates these
associations. First, we hypothesize that greater anticipation and experiences of discrimination are predictive of
infrequent testing for sexually transmitted infections, including HIV, and lower pre-exposure prophylaxis (PrEP)
use, retention in care, PrEP adherence, and PrEP protection over a 36-month follow-up period among Black
MSM in the Deep South. Next, we hypothesize that differing levels of resilience will moderate the associations
between discrimination and HIV prevention. Finally, we will conduct qualitative focus groups with social
mapping to validate the quantitative results in Aims 1&2 and to identify and/or adapt effective social-structural
and/or strengths-based interventions to mitigate the effect of SRD on PrEP outcomes among Black SMM.
Three integrated specific aims are proposed to test these hypotheses.
In Specific Aim 1, to evaluate the relationships between SRD factors and PrEP continuum outcomes among
Black SMM in two Southeastern U.S. cities over a 36-month follow-up period, using multilevel modeling
techniques. In Specific Aim 2, to determine the moderating effects of resiliency factors on the relationships
between SRD factors and PrEP continuum outcomes among Black SMM in two Southeastern U.S. cities
through moderation analyses. And finally, in Specific Aim 3, to a. gain contextually-grounded explanations of
the quantitative results via focus groups; b. “geo-narratives” of the geographical landscape of Black SMM
using social mapping; and c. synthesize the quantitative and qualitative results via data triangulation methods.
Broadly, this research will enhance our understanding of how SRD discrimination contributes to inequities
in HIV and provide insight into three long-standing questions in the field of HIV epidemiology: (1) minority
stress mechanisms that contribute to HIV prevention outcomes, (2) intrapersonal traits that buffer the
associations of minority stressors with HIV prevention, and (3) identification and/or adaptation of social-
structural or strengths-based interventions to mitigate HIV among Black SMM.

Public health relevance
PROJECT NARRATIVE Stark inequities in pre-exposure prophylaxis (PrEP) use, retention in PrEP care, PrEP adherence, and PrEP protection persist among Black sexual minority men (SMM) and HIV incidence continues to increase among certain segment of Black SMM, especially those in the Southeastern United States (U.S.). This signifies a critical failure of the U.S. public health system and the need to: (1) investigate the concomitant and intersecting associations of anticipated, perceptions, and experiences of RD at multiple levels with key PrEP continuum outcomes; (2) assess the moderating effects of resiliency factors on the link between multilevel RD and PrEP continuum outcomes, and (3) triangulate quantitative, qualitative and social mapping data to validate causal relationships and identify possible social-structural and/or strengths-based interventions that may mitigate the effects of multilevel RD on PrEP continuum outcomes. The combination of novel multilevel RD and resiliency measures and robust phenotypic PrEP biomarker data, in addition to the study population and location, represents a significant advancement in HIV prevention and has the potential to increase the number of Black SMM who initiate and adhere to PrEP and ultimately reduce HIV incidence, which aligns with the federal plan to End the HIV Epidemic by 2030, the National HIV/AIDS Strategy and funding priorities of the NIH.